MUSCLE MASS AND HYPOTHERMIA IN THE ELDERLY

The purpose of this study is to investigate the effects of the loss of muscle mass associated with aging (sarcopenia) on thermal balance and thermoregulatory responses to a cold environment. Older individuals are more at risk for hypothermia than younger individuals. One possible explanation for this increased risk may be decreased muscle mass (fat- free weight). Therefore, the aim of this study is to compare the thermoregulatory responses of older individuals with different fat free weights to a cold stress.